United State Renal Data System ^ Quality of Life/Rehabilitation Special Study Ctr

This contract is in support of the United State Renal Data System (USRDS) national registry. The USRDS is a longitudinal registry of all persons in the US who have end stage renal disease (ESRD). This includes all persons on dialysis and recipients of kidney transplantation. The data base is inclusive of all incident cases of ESRD from 1980 to the present. Information on ESRD patients include date and cause of renal failure as well as co-morbid conditions. In addition, follow-up data include mortality, hospitalization and other indicators of morbidity and disability, as well as expenditure data. In addition, the USRDS includes similar information on persons with chronic kidney disease. Although the Medicare ESRD program was started under the assumption that persons with ESRD would be able to return to work after starting dialysis, very few do. In addition, persons with ESRD have very low measures of exercise tolerance and general activity levels.